TASK D15: FILARIASIS RESEARCH REAGENT CENTER

This contract provides for the development and standardization of nontraditional animal models for infectious diseases and may include candidate product efficacy testing, including GLP studies to support licensure.